Biostatistics and Bioinformatics Core

SUMMARY/ABSTRACT – BIOSTATISTICS AND BIOINFORMATICS CORE (CORE 1)
The Biostatistics and Bioinformatics Core (Core 1; C1) will provide data management and analytical
competencies to all projects (P1–P3) and cores (C2, C3, and the Administrative Core). C1 personnel will work
closely with the other project and core leaders to support study design, data collection, management, data
curation, statistical analysis, interpretation, and publication of the study outcomes. C1 will play a crucial role in
creating data collection instruments and managing data in REDCap systems to ensure proper data validation.
C1 personnel will also create standardized requirements and scripts to perform regular data quality checks,
develop a formal data sharing protocol, and oversee the data request and distribution. The biostatistics
personnel from C1 were actively involved in producing each project protocol, including sample size and power
analysis. We will work with each project leader to provide state-of-the-art statistical and bioinformatics
collaboration and consultation throughout the study and use novel methodologies to analyze and interpret
data. We will use a high-performance computing cluster with 90 compute nodes to run all bioinformatics
analyses. As an integral part of the PPG, all C1 members will attend all the PPG's monthly meetings and focus
on analyzing and interpreting data generated by the projects and other cores. C1 will also educate the junior
members of the PPG on biostatistics and bioinformatics methods and techniques.